A systems biology approach to explain sex differences in aging

ABSTRACT
The risk of mortality is higher for human males than females at all ages and in almost every country, and this
same pattern holds in most other mammalian species as well. In studies of genetic, environmental or
pharmacological interventions designed to ameliorate the effects of aging, the responses are frequently sex-
biased, and in some cases, benefits are limited to just one sex. Researchers have been encouraged by NIH’s
“Sex As a Biological Variable” (SABV) initiative to consider the effect of sex in aging-related laboratory and
clinical studies. However, the focus has been on sexual dimorphism due to dichotomous differences (e.g., XY
versus XX sex chromosomes). This typological approach can successfully determine if sex affects outcome, but
fails to address why these sex differences occur. This gap in existing approaches represents a critical unmet
need in the field of aging research. Recent published studies and preliminary work from our lab show that the
effects of sex on complex traits are far from dichotomous, falling along a continuum. In fruit flies, for example,
both the magnitude and direction of difference between males and females in lifespan vary among genotypes.
Preliminary data suggest the same is true for the sex-specific response to treatments designed to improve
healthy aging in lab organisms. This shift from a dichotomous to continuous perspective on the effects of sex
reflects an important conceptual innovation. Based on these findings, the central hypothesis tested here is that
biological sex differences fall along a continuum shaped by sex interacting with the underlying genotype, and
that the mechanisms contributing to this continuum are discoverable. The primary goal of this proposal is to use
a systems biology approach with metabolomic profiling to discover the molecular mechanisms that underlie
genotype-dependent effects of sex on aging and age-related traits. As in much of our prior work, we use the
Drosophila Genome Reference Panel, a powerful model of natural genetic variation. We combine this genetic
resource with profiles of the metabolome, which measures the small molecules that make up the structural and
functional building blocks for all traits. To test our central hypothesis, we explore two questions. First, we use
measures of metabolome profiles, including measures within each sex and the difference between sexes, to
predict and explain genetic variation in sex differences for lifespan and stress resistance in Drosophila. Second,
we test the ability of the metabolome to predict and explain sex differences in response to rapamycin, a drug
found to extend healthy lifespan in diverse lab organisms. We employ proteomic and transgenic approaches to
validate putative mechanisms for sex differences suggested by metabolomics. The long-term goal of this
research is to lay the groundwork for improved sex-specific disease prediction, prognosis, diagnosis, treatment
and prevention in human populations.

Public health relevance
NARRATIVE The risks of age-related disease and death differ dramatically between the sexes, but we do not know why. To fill this critical gap in our understanding, this R21 proposes a highly innovative approach based on systems biology profiles in the fruit fly, a proven and powerful genetic model for the study of aging and disease. This work will help us determine the causes of sex differences in age-related disease risk and could ultimately help clinicians to more accurately carry out disease diagnosis, prognosis, and treatment.